Fusion inhibitors that block host-to-host transmission of SARS-CoV-2

Coronaviruses (CoVs) can cause life-threatening diseases. The recently emerging coronavirus-related illness
was named coronavirus disease 2019 (abbreviated “COVID-19”) by the World Health Organization. COVID-19
is caused by SARS-CoV-2. Like its predecessors SARS-CoV and MERS-CoV, SARS-CoV-2 (S-CoV-2) is a
betacoronavirus that is thought to have originated in bats. Originally its spread was animal-to-human, but
human-to-human transmission is now widespread. No vaccines and treatments for COVID-19 are available,
and these are urgently needed to address the outbreak as well as inevitable ongoing infection. Antivirals that
target viral entry into the host cell have been proven effective against a wide range of viruses. In this proposal,
we will apply the results of our fundamental research to the development of novel peptide inhibitors of SARS-
CoV-2 entry. We have designed lipid-conjugated fusion-inhibitory peptides that efficiently inhibit coronavirus
infection in in vitro, ex vivo, and in vivo. We propose to synthesize and evaluate novel lipidated peptides that
have enhanced efficacy. These inhibitors will be evaluated for antiviral activity against live SARS-CoV-2 virus.
Promising candidates will be tested in transmission experiments in a ferret model. This application will
determine whether our approach to entry inhibition of SARS-CoV-2 prevents infection in vivo.
1. To optimize antiviral potency of HRC-lipopeptide fusion inhibitors.
2. To pre-clinically evaluate HRC-lipopeptide fusion inhibitors biodistribution, toxicity and protection
against SARS-CoV-2 infection or transmission in vivo.

Public health relevance
The recent and ongoing outbreak of SARS-CoV-2 highlights the need for a streamlined approach to develop effective antivirals; there are no vaccines or approved antivirals. We propose to apply our established strategies for developing viral-entry preventing peptides to develop SARS-CoV-2 peptide antivirals based on viral genetic information; based on our previous findings we have high confidence that we can provide effective COVID-19 prophylaxis using fusion inhibitors. We will also assess the potential of our antivirals to block host- to-host transmission.